Michigan Center on the Demography of Aging

Project Summary
This proposal requests funding for Years 27-31 of Michigan Center on the Demography of Aging (MiCDA). The
overarching goal of MiCDA is to advance research on the demography of aging in three signature areas: (1)
Enriching data infrastructure to advance breakthroughs in the demography of aging; (2) The changing
demography of late-life disability and dementia and related family caregiving issues; (3) Life course determinants
of health and wellbeing in later life and related disparities. Research will be promoted through the following cores:
The Administration and Research Support Core (Core A) will plan and execute administrative functions for
MiCDA's activities; manage MiCDA's Advisory Committee; and lead strategic planning and visioning while
enhancing MiCDA's visibility with key constituencies. The Program Development Core (Core B) will continue its
focus on strengthening MiCDA's faculty and funding pilot projects that highlight signature themes. The External
Innovative Network Core (Core C) will facilitate new research in the Center's signature areas through three
ongoing and one new network: TRENDS, which will formally expand its focus to include both disability and
dementia trends; HRS Sister Studies, which will continue to provide technical assistance to emerging studies
abroad; Longitudinal Studies of Aging in the U.S., which will continue to focus on emerging survey
methodological and measurement issues that cross-cut NIA-funded panel studies; and a new network on the
Demography of Family Caregiving, which will emphasize how changes in fundamental demographic processes
are influencing various facets of family caregiving for older adults. The Remote Data Enclave Core (Core E) will
provide a Virtual Data Enclave to facilitate access to restricted aging-related data. Goals for the coming cycle
include expanding the MiCDA enclave's data products and expanding its user base while ensuring continued
reliable system performance.

Public health relevance
Project Narrative MiCDA promotes research on the demography of aging, focusing on issues related to (1) Enriching data infrastructure to advance breakthroughs in the demography of aging; (2) The changing demography of late-life disability and dementia and related family caregiving issues; (3) Life course determinants of health and wellbeing in later life and related disparities. Findings contribute to our understanding of the health and wellbeing of older adults in the aging US population and internationally.